Molecular Mechanisms of Immune Thrombocytopenia in Transfusion Medicine

OVERALL COMPONENT – PROJECT SUMMARY/ABSTRACT
This revised application for a Program Project seeks support for a coordinated, multi-disciplinary investigation
of molecular mechanisms that underly clinically important immune-mediated thrombocytopenic and thrombotic
disorders. The Program is housed at Versiti's Blood Research Institute and Children's Hospital of Philadelphia –
both nationally renowned facilities with long-standing commitments to basic, translational, and clinical blood-rela-
ted research, particularly in the areas of platelet immunology, platelet activation, thrombosis, and B cell immuno-
biology. These disciplines are of programmatic significance to the NHLBI, and of central importance to trans-
fusion medicine and classical hematology - disciplines that, despite their impact on the nation's health, are cur-
rently underrepresented in both human and financial resources. Our application reflects ongoing, close collabor-
ative ties amongst the Project Leaders, some for more than three decades, and is bolstered by a strong history
of interdependence that has allowed us to tackle thematically related issues of clinical relevance and importance.
The central unifying theme of our application is to build on and develop a deeper understanding of clinically rele-
vant immunological insults that lead to thrombocytopenia and downstream pathophysiological sequelae in the
fetus, newborn, and adult. The Program comprises three highly synergistic, interdependent Projects, each of
which is characterized by (1) examination of an unpredictable pathology attributable to a subset of antigen-spe-
cific antibodies that, in addition to causing thrombocytopenia, also adversely affect other cell types, and (2) judi-
cious use of preclinical mouse models that are specifically designed to investigate the etiology of different forms
of immune thrombocytopenia. Project 1: The Immunobiology of Fetal/Neonatal Alloimmune Thrombocytopenia
(FNAIT) employs a novel antigen-specific mouse model and a battery of clinically relevant monoclonal antibodies
to define the functional significance of specific maternal antibody subpopulations that contribute mechanistically
to, and may be diagnostic of, the severity of FNAIT. The etiology of this disorder is examined by exploring routes
of antigen exposure that cause maternal alloimmunization to occur unpredictably in first pregnancies. Project 2:
The Immunobiology of Heparin-induced Thrombocytopenia (HIT) uses sophisticated human antibody cloning
techniques and analysis to identify and characterize the specific pathogenic antibody subpopulations that cause
HIT, and explores an intriguing role for the gut microbiome in the etiology of this man-made immunological dis-
order. Project 3: The Immunobiology of Vaccine-induced Thrombotic Thrombocytopenia (VITT) examines novel
mechanisms by which platelet factor 4, platelet basic protein, and neutrophil activating peptide 2 contribute to
the etiology of this rare, but life-threatening, immunologically mediated disorder. Taken together, there is strong
scientific and programmatic rationale for this comprehensive effort to examine molecular and cellular mechan-
isms that underly the immune-mediated thrombocytopenias. Insights and concepts derived from these basic
studies should enhance the development of novel, clinically relevant diagnostic and therapeutic applications.

Public health relevance
OVERALL COMPONENT – PROJECT NARRATIVE This is a revised application for a Program Project Grant seeking to provide support for a coordinated, multi- disciplinary investigation of the molecular mechanisms that underly clinically relevant immune-mediated thrombocytopenic disorders that are of importance to clinicians, scientists, and patients alike. The central unifying theme of our application is to develop a deep understanding of a wide range of immunological insults that lead to thrombocytopenia and downstream sequelae in the fetus, newborn, and adults. The Program takes place at the Versiti Blood Research Institute of Versiti's Blood Center of Wisconsin - a nationally renowned facility strictly focused on and devoted to all aspects of blood-related research, including transfusion medicine, hematology, and immunobiology, and within the Pediatric Hematology Division of Children's Hospital of Philadelphia - an elite scientific research institution located on a premier academic medical campus.